Brain and Behavioral Development in Autism Spectrum Disorder

Adolescence is a complex time of heightened self-consciousness, risk taking and peer orientation which may be
especially challenging for teens diagnosed with autism spectrum disorder (ASD). Longitudinal magnetic
resonance imaging (MRI) studies of children with ASD that begin at diagnosis and extend into adolescence are
extremely rare. This is a critical gap since adolescence is also a period of profound brain changes. The MIND
Institute Autism Phenome Project (APP) was initiated in 2006 to discover multilevel phenotypic information
enabling definition of clinically meaningful subtypes of ASD. Nearly 300 families have completed an initial
assessment with successful MRI. The APP includes autistic children with all severity levels and co-occurring
conditions such as anxiety and intellectual disability. Children with ASD and age-matched typically developing
controls had their first MRI at 2-3.5 years of age and up to 3 additional scans between ~4 and ~12; 773 MRI
scans have been acquired. We propose to extend this study to a 5th time point in middle adolescence (14-17
years). A guiding theme of this research is that different trajectories of brain development will differentiate subsets
of children with ASD and some of these differences will become most apparent as the child enters adolescence,
which coincides with pubertal development. Because we have carried out pediatrician-based Tanner staging at
multiple time points, we will be able to evaluate how puberty influences the emergence of these developmental
brain differences across all aims. Capitalizing on the large amount of longitudinal structural MRI data acquired
to date, we will use structural covariance analysis and other network level strategies to evaluate developmental
differences in gray matter structure across several domain specific networks. Focusing on intrinsic connectivity
networks implicated in the triple network model of autism, we predict reduced magnitude and extent of salience
and central executive networks in ASD and greater extent with anterior-posterior decoupling in the default mode
network. The amygdala is a brain region consistently reported to be altered in ASD. Our previous MRI and
postmortem research indicate that there is an abnormal trajectory of amygdala growth in autism with enlargement
early on and atrophy in adolescence. We will investigate longitudinal growth of the amygdala to test the
hypothesis that it undergoes atrophy in adolescence in ASD. We hypothesize that this preferentially involves
those with a form of co-occurring anxiety disorder and is different from teens with anxiety but not ASD. We will
also address the critical under-studied question of what neural alterations differentiate children with ASD with,
and without, intellectual disability. We will investigate the maturation of brain regions and networks associated
with intellectual and language function to explore differences between children with ASD and low verbal/cognitive
performance from those with normal verbal/cognitive performance. Finally, we will evaluate trajectories of autism
severity change into mid adolescence and explore the neurobiological underpinnings of these changes. We
predict that persistent alterations in the salience network will be associated with increased severity over time.

Public health relevance
We have previously monitored brain and behavioral development in nearly 300 autistic and typically developing children in the MIND Institute’s Autism Phenome Project. Up to 4 MRI scans have been carried out when the child is between 3 and 12 years of age and we propose to do an additional scan between 14-17. We have discovered that subgroups of children with autism have different, altered patterns of brain development. We have also found that 69% have serious anxiety symptoms and nearly 30% of children improve in symptom severity whereas 18% increase and about 50% stay the same. We propose to evaluate brain and behavioral changes as these children enter adolescence. The goal is to enable more effective targeted treatments for defined subgroups of individuals with autism.